INFLUENCE OF CALCIUM ON BONE MASS FORMATION DURING PUBERTY

This longitudinal study, now in its seventh year, assesses the effects of increased calcium intake on bone mass formation in females during puberty and early adolescence using double-blind, placebo-controlled trials of calcium supplements.